NEDD4 in right ventricular development

PROJECT SUMMARY
Abnormalities in right ventricle (RV) development are associated with congenital heart disease (CHD).
Although developmental origins and initial specification of the RV has been a subject of intense study, critical
molecular pathways involved in subsequent RV growth and expansion at later stages following chamber
formation remain to be explored. Our analysis of mice with constitutive cardiomyocyte (CM)-specific knockout
(cKO) of Nedd4 revealed a unique RV-specific phenotype. Deletion of Nedd4 during early embryonic stages by
Xmlc2-Cre, which specifically expresses in early developing CMs from E7.5, resulted in dramatic RV dilation at
postnatal stages, with defects observed at E14.5. Conversely, the LV, as well as the pulmonary vessels,
appeared normal. NEDD4 is a HECT E3 ubiquitin ligase highly expressed in CMs. The severe RV-specific
abnormalities in Nedd4 cKO highlight the importance of NEDD4 in RV development. To explore molecular
mechanisms by which loss of NEDD4 in CMs resulted in RV development defects, we performed proteomics
analysis of cKO and control ventricles at E14.5. Differentially expressed proteins were enriched in pathways
involved in cellular membrane organization, vacuolar transport and vesicle-mediated transport. To determine
whether loss of Nedd4 disrupts cellular membrane organization, we performed TEM analysis on cKO and
control hearts at E14.5. Intriguingly, a massive expansion of endoplasmic reticulum and perinuclear space
accompanied by large cellular vacuoles was observed in RV tissues of cKOs, while the LV displayed normal
ultrastructure, suggesting that Nedd4 is essential for cellular membrane organization in RV CMs. To determine
the ongoing CM-specific requirement for NEDD4 in RV development at different stages, we generated
tamoxifen inducible CM-specific Nedd4 knockout mouse models to ablate Nedd4 at embryonic, perinatal or
adult stages. Our preliminary data revealed that ablation of Nedd4 in either postnatal or adult CMs did not
result in the dilated RV phenotype observed in Nedd4 cKOs, suggesting a specific requirement for Nedd4 in
embryonic CMs, although the critical time window during which Nedd4 controls RV development, and detailed
molecular mechanisms by which it does so remain unknown. The unique RV phenotype of Nedd4 cKO mice
will allow us to uncover RV-specific pathways required for heart development, and to model the impact of RV
dysfunction on cardiac performance, of relevance to CHDs associated with RV dysfunction. We will test the
hypothesis that Nedd4 plays essential roles in CM subcellular membrane organization and RV development.
Our Specific Aims are: 1) To elucidate the role of Nedd4 in RV development, as well as the impact of
congenital RV defects on cardiac performance, by histological, physiological, biochemical, and molecular
analyses of constitutive Nedd4 cKO mice; and 2) To determine the critical window during which Nedd4 is
required for RV development by analysis of Tnnt2MerCreMer:Nedd4 inducible CM-specific knockout (ticKO) mice.

Public health relevance
PROJECT NARRATIVE Abnormalities in right ventricle (RV) development are associated with congenital heart disease (CHD), however lack of appropriate animal models has hindered studies of the molecular basis of RV development following chamber formation. Our analysis of mice with cardiomyocyte (CM)-specific knockout (cKO) of NEDD4 (Neural precursor cell expressed developmentally downregulated protein 4), a HECT E3 ubiquitin ligase, revealed a unique RV-specific phenotype. Proposed studies are aimed to elucidate the role of NEDD4 in RV development, as well as the impact of congenital RV defects on cardiac performance, by histological, physiological, biochemical, and molecular analyses of constitutive Nedd4 cKO mice, and to determine the critical window during which NEDD4 is required for RV development by analysis of tamoxifen-inducible Nedd4 knockout mice.